Administrative Core

Overview
The overall goal of the Administrative Core is to provide scientific, fiscal, and organizational coordination of all
the activities of the Projects and Cores, facilitate interactions, regular meetings and technology/sample/data-
sharing, and provide oversight and strategic planning for the program as a whole.
The aims of Core A are:
1. General Administration including the management of the communication and interaction between the
projects, communicate with the NIA/NIH program Officers and Directors including the filing of progress reports
and publications after acceptance, fiscal and accounting services for all Projects and Cores. This includes
travel reimbursements and meeting logistics, maintaining the project website for experiment planning,
inventory and data sharing, and manuscript preparation.
2. Facilitate Meetings and Data/Reagent Sharing including organizing bimonthly meetings of all
investigators, all meetings to be held at the USC UPC Campus, and organize an annual meeting with the
internal advisory board and meetings with the external advisory board every other year, and coordinate the
sharing of materials, supplies, cells, and animals between the different projects.
3. Progress Curate the data produced by the various constituents of each Core and Project, and prepare and
distribute reports by the Internal and External Advisory Committees, and provide feedback to each Core and
Project to ensure that the goals of the program project are met in a timely manner.
4. Communication Work with the USC and Harvard executives to expose university students, researchers
and faculty to novel aging research-based strategies to prevent and treat diseases and enhance their interest
in biogerontology, and work with the university administration to organize symposia and public lectures related
to biogerontology-based approaches to prevent and treat diseases, utilize the project website to inform and
educate the public, researchers and clinicians about the progress of the research performed as part of this
P01, the parallel clinical studies, and the progress in the area of biogerontology-based approaches in
biomedicine.

Public health relevance
Project Narrative: The overall goal of the administrative core is to provide scientific, fiscal, and organizational coordination of all the activities of the Projects and Cores, facilitate interactions, regular meetings and technology/sample/data- sharing, and provide oversight and strategic planning for the program as a whole.